Discovery and validation of CYP8B1 Inhibitors as probes for targeting Hepatocellular Carcinomas (HCC)

PROJECT SUMMARY
Hepatocellular carcinoma (HCC) is the third leading cause of cancer deaths worldwide. FDA-approved small
molecule drugs for the treatment of HCC primarily target kinases within cancer cells. Current treatments for HCC
are ineffective and cancer resistance is common while treated individuals obtain only brief survival. The
development of cancer involves a complex interplay of various proteins in addition to dysregulation of kinases.
There is a significant lag in discovery of small molecules that modulate non-kinase targets for the treatment of
HCC. Our long-term goal is to meet the critical unmet need for innovative pharmacological therapies with
desirable safety profiles and durable treatment effects for HCC, including metabolic dysfunction associated HCC.
Bile acids (BAs) play important roles in regulating metabolism, inflammation, and cancer. CYP8B1 (also known
as sterol 12-alpha-hydroxylase), which is exclusively expressed in the liver hepatocytes, functions to specifically
control the 12α-hydroxylated (OH)/non-12α-OH BA ratio within the BA pool. CYP8B1 deficiency generates
beneficial profiles of BA and gut microbiota, thereby improving systematic metabolism and immunity,
suppressing tumorigenesis, as well as inducing apoptosis. Thus, CYP8B1 is a novel and promising therapeutic
target for drug discovery to treat HCC. Indeed, rodents with a natural Cyp8b1 gene deletion (such as the naked
mole-rat) are cancer resistant, and our preliminary research observed less aggressive tumors in Cyp8b1 KO
mice in a rapid HCC model. We hypothesize that CYP8B1-specific inhibitors may provide a unique
pharmacological approach to treat HCC. Therefore, the direct objective of this grant proposal is to develop
selective small molecule inhibitors against CYP8B1 to treat HCC, including metabolic dysfunction associated
HCC. To the best of our knowledge, we are the first group to explore anti-HCC drug discovery targeting a non-
kinase target — a CYP family member to develop selective CYP8B1 inhibitors. This proposal is in collaboration
with Sanford Burnham Prebys (SBP) Medical Discovery Institute, a well-established, NCI-CBC dedicated center
and NCI-designated basic cancer center. The assembled team is well-qualified to complete the following Specific
Aims: 1) To identify CYP8B1 inhibitors via HTS of the SBP ~250K compound library; 2) To validate hits for
potency, specificity, and rationalize SAR by structural & biophysical studies; and 3) To identify the mode of action
(MOA) and biological effects of validated CYP8B1 inhibitor lead candidates on HCC. The completion of the
proposed studies will have identified novel, potent, and specific CYP8B1 inhibitors, providing not only a small
molecule tool for researching the crucial role of CYP8B1 in cancer (scientific), but also offering prototype lead
candidate(s) for developing potential first-in-class pharmaceutical treatment for HCC with translational
significance (translational) in follow-up grant studies.

Public health relevance
PROJECT NARRATIVE Hepatocellular carcinoma (HCC) is a common and lethal malignancy worldwide that seriously threatens human health and life. The proposed research is highly relevant to public health because current small molecular treatments for HCC still show limitations such as short overall survival period and drug resistance, and they primarily target kinases, although cancer development involves a complex interplay of various proteins in addition to dysregulation of kinases. The novel non-kinase target and novel small molecule inhibitors to be discovered in this proposal fit the purview of NCI’s mission to support discovery research for the identification of small molecules that function as inhibitors of cancer targets for therapy by targeting metabolic and immune environment regulating tumor growth.